Molecular Basis of Coats Plus Disease

The Coats plus syndrome is a rare and life-threatening genetic disorder characterized by multi-system
developmental defects that lead to bilateral exudative retinopathy, retinal telangiectasias, growth retardation,
intracranial calcifications, bone abnormalities, gastrointestinal vascular ectasias, and common early-aging
pathological features. Like many other developmental disorders, Coats plus is caused by defects in genes
involved in maintaining global genome integrity. Specifically, it is caused by loss-of-function mutations in the
human CTC1/STN1/TEN1 (CST) complex, which is a trimeric complex that preferentially binds to G-rich ssDNA
or ss-ds DNA junctions and is critical for preventing genome instabilities arising from replication perturbation. We
hope to aid in better understanding of disease development and designing of effective therapeutic strategies by
investigating the mechanisms governing genome stability under replication stress. In response to fork stalling,
signaling cascades activate multiple pathways including fork reversal, translesion synthesis, repriming
downstream of stalled sites, and dormant origin firing to rescue stalled replication. Activities of these pathways
need to be tightly regulated to ensure replication fidelity. The objectives of this proposal is to delineate a novel
signaling pathway in response to replication stress, elucidate how it regulates protein interplays and recruitment
at stalled forks, and understand the mechanism regulating the repriming pathway. In Aim 1, we hypothesize that
a calcium-dependent signaling pathway phosphorylates STN1 to activate CST at stalled forks to protect the
stability of stalled forks. We will elucidate this new signaling pathway and determine how this pathway
antagonizes unscheduled nascent strand DNA degradation and regulates fork protection. In Aim 2, we will
investigate how this signaling pathway regulates the interplay of single-strand DNA binding proteins at forks and
other fork binding proteins. In Aim 3, we will investigate the mechanism for restricting excessive repriming to
prevent ssDNA gap formation and genome instability. We will combine highly sensitive cell-based analyses,
single-molecule and powerful biochemical assays to accomplish the goals of the proposed research. We expect
that our efforts will identify new factors and pathways regulating the rescue of stalled replication and the
preservation of genome stability.

Public health relevance
Project Narrative Defects in genes involved in replication stress response often lead to neurodevelopmental disorders and predisposition to cancer. The Coats Plus disease, caused by dysfunction of genes involved in combating replication stress, is a rare genetic disease characterized by developmental failure of multiple vital organs including brain, eye and GI tract. The proposed research aims to reveal a new signaling pathway regulating the cellular response to replication stress and is expected to yield new mechanistic insights into how cells protect genome stability during perturbed replication and how genome instability leads to disease development.